Mechanism of Defective Incretin Action in Beta Cells during Type 2 Diabetes Mellitus

PROJECT SUMMARY/ABSTRACT
The incretin-mediated potentiation of glucose-stimulated insulin secretion (GSIS) accounts for 50% of
postprandial insulin secretion and is essential for physiologic glycemic regulation. Upon nutrient stimulus, the
two principal incretin hormones glucose-dependent insulinotropic peptide (GIP) and glucagon-like peptide-1
(GLP-1) are secreted, respectively, from intestinal endocrine K- and L-cells and reach β-cells via the circulation,
where they bind their receptors, GIP receptor (GIPR) and GLP-1 receptor (GLP-1R) to amplify GSIS.
While circulating incretin hormone levels are not impacted by T2DM, incretin effects on β-cell GSIS are
significantly diminished in T2DM patients. However, the precise mechanisms underlying diabetes-associated
blunting of incretin signaling in β-cells remain unclear.
In T2DM, pharmacologic means to increase circulating GLP-1 levels improves GSIS and glycemic control.
In contrast, the GIP-mediated incretin effect is notably absent in T2DM; and pharmacologic means to increase
circulating GIP concentrations is not met with any GSIS improvement. The molecular mechanisms underlying
diminished response to GLP-1 and absent response to GIP in T2DM remain poorly understood.
T2DM is in part linked to a chronic inflammatory state with increased levels of local and circulating
inflammatory cytokines that negatively impact insulin action in peripheral tissues and negatively impact the
endocrine pancreas. We have therefore examined the role of pro-inflammatory cytokines that are elevated in
T2DM on incretin signaling in islet -cells. Conversely, we have also interrogated the anti-inflammatory
cholinergic signaling system through nicotinic acetylcholine receptors (nAchR) in modulating incretin signaling.
Based on our preliminary studies, we hypothesize that TNFα - signaling through its receptor TNFR1 on β-
cells - activates the Ser/Thr G-protein receptor kinase 2 (GKR2) in a non-canonical manner to suppress Gαs-
activation and cAMP synthesis by ligand activated GIPR and by GLP-1R. Thus, our findings establish a
mechanistic link between inflammatory cytokines in T2DM with diminished incretin signaling in β-cells.
Our preliminary studies also indicate that in a murine model of T2DM, stimulating the α7 nicotinic
acetylcholine receptor (α7-nAchR) reactivates GIPR signaling in β-cells to potentiate GSIS and improve
glycemia. Our mechanistic studies indicate that α7-nAchR signaling phosphorylates (TNFα-activated) GRK2 at
serine 670 to counteract its inhibitory effects on GIPR and GLP-1R-mediated cAMP synthesis.
We now seek to expand our novel and exciting findings specifically a) to understand the role of TNFR1-
GRK2-mediated signaling on in vivo β-cell function, on GIP and GLP-1R action as well as how TNFR1 signaling
modulates α-cell gene expression in the context of obesity and T2DM; b) to specifically understand the role of
GRK2 in mediating resistance to β-cell incretin action in T2DM; and c) to understand the beneficial role of anti-
inflammatory α7-nAchR signaling in β-cells in the context of T2DM.
We will use complementary in vivo and in vitro approaches to elucidate these important signaling pathways
in β-cells using newly generated unique mouse models as well as in vitro in human islets and β-cells.
The outcomes of our studies will yield important insights into how inflammatory cytokines of T2DM impact
incretin signaling and β-cell function. Our proposed studies will also provide new insights into the effects of
nicotinic acetylcholine signaling in β-cells. Finally, our studies identify potentially new receptor targets with the
potential to ameliorate β-cell dysfunction in T2DM.
.

Public health relevance
NARRATIVE Low level chronic inflammation is a hallmark of Type 2 diabetes mellitus. How inflammatory cytokines affect the function of pancreatic beta cells is insufficiently understood. The present project examines the negative impact of the inflammatory cytokine tumor necrosis alpha (TNFα) on the response of pancreatic beta cells to incretin hormones. Incretin hormone action is defective in diabetes and which are critical for normal glycemic control. We will also examine how targeting anti-inflammatory nicotinic acetylcholine receptors can restore the defective incretin action in beta cells and ameliorate diabetes mellitus.